Functional profiling of OSP-specific and other antibodies during shigella infection

PROJECT SUMMARY/ABSTRACT
This is a competitive renewal application for an ongoing field-immunology Shigella project actively
enrolling child participants in Bangladesh. Shigella infection is a leading cause of diarrheal illness in
young children in resource-limited settings, and results in tens of thousands of deaths each year.
Protection against shigellosis is associated with antibodies targeting O-specific polysaccharide
(OSP), but immune responses against other antigens have also been noted to correlate with
protection. Functional attributes of anti-shigella antibodies have also been noted to correlate with
protection, including complement activation and ability to induce host cell phagocytic activity. Despite
this, a shigella OSP-conjugate vaccine failed to protect young children in a field trial, despite
providing protection in older children and adults. We propose that such issues may reflect differences
not only in antibody magnitude (titer) following vaccination, but also differences in antibody functional
effector attributes, including Fc interactions with the innate immune system. Such differences have
been noted to correlate with protection against a range of infectious pathogens. To address this, we
propose (1) to define antibody functional and biophysical attributes associated with protection against
shigellosis, including in young children, using an ongoing and actively enrolling household contact
study design approach in an informal settlement area in Dhaka, Bangladesh. We propose to
complement this effort with (2) analysis of functional antibody responses correlating with protection
from severe disease in children in Bangladesh (continuing our ongoing and actively enrolling index
case enrollment study in Dhaka), and we propose (3) to assess antibody-afforded mechanisms of
protection involving innate cell activation and functional antibody activity using a library of
engineered-Fc antibodies from monoclonal anti-Shigella antibodies cloned from children with
shigellosis in Bangladesh. We anticipate that we will identify a profile of antibody attributes that
correlate with protection against shigellosis (incident infection and disease severity) and that we will
identify mechanisms of protection afforded by such anti-Shigella antibodies. This knowledge will be
shared in Open Access fora, will continue building upon our collaborative international capacity
building efforts, and will critically guide evaluation efforts for vaccines currently being developed to
protect children in resource-limited areas from shigellosis.

Public health relevance
NARRATIVE Relevance to public health Anti-OSP and other antibody responses have been associated with protection against shigella infection. A number of shigella vaccines are being developed; however, we have limited knowledge of the functional attributes of anti-Shigella antibodies and their correlation with protection, especially among young children in resource-limited settings. We propose to address these issues in this project.